Medical Genetics Research Training Grant

The field of medicine is experiencing a genomics revolution. The need to train physician scientists and
investigators of diverse backgrounds experienced in genomic and genetic methodologies and able to translate
basic science discoveries in genomics into clinical care has never been greater. The major goal of this
postdoctoral research training program is to train the future leaders of Medical Genetics and Genomics who
will emerge from a variety of training pathways with varying amounts of research experience. Postdoctoral
trainees with M.D. or M.D., Ph.D. degrees with clinical training in Medical Genetics, Pediatrics, Medicine,
Psychiatry, Pathology, and other specialty areas will be eligible for support from this training grant. Funding for
5 training slots per year is sought. The clinical training years (typically year 1 for Categorical Medical Genetics
trainees and years 1-3 for combined Pediatric and Medical Genetics trainees) is funded by the Perelman
School of Medicine at the University of Pennsylvania (UPenn) and The Children’s Hospital of Philadelphia
(CHOP), while funds for the research years of the overall training program are sought from this training grant.
During the Medical Genetics Research Fellowship years supported by this Training Grant, the fellow devotes a
minimum of 85% effort to research in a basic science laboratory. Research opportunities are extremely diverse
with training in the laboratories of 42 Faculty from 6 core departments at CHOP/UPenn. Fields of research may
encompass those areas that impact human genetics including, but not limited to: genomics, molecular
genetics, cytogenomics, biochemical genetics, epigenetics, mitochondrial genetics, developmental biology,
cellular biology, bioinformatics, systems biology, pharmacogenetics, gene therapy and others. During the
research years, the trainee also takes seminar courses, attends journal clubs, research meetings, and
departmental research retreats, and carries out minimal clinical activities, not to exceed 15% effort. Training
stipends for the 2-3 years of research are requested in this application. The M.D. trainee will likely require
further research training (not covered by this training grant), which might be acquired through an additional
postdoctoral research experience or a protected faculty appointment with considerable mentoring from a senior
faculty member. The training program outlined in this proposal is built on our past rack record of success and is
committed to recruiting a diverse group of highly talented postdoctoral trainees to a rich and supportive
research environment and through a rigorous program of training, mentorship and oversight develop the future
physician-scientist leaders in Medical Genetics and Genomics.

Public health relevance
We are in the midst of a medical revolution at the center of which is genetics and genomics, this period in medical history will likely be known as the “Genomics Era” and underscores the need for intensive and high quality human genetic research training of clinicians (M.D. and M.D., Ph.D.) trained in Pediatrics, Medicine, Psychiatry, Pathology and other specialties. This research training program seeks to provide this training primarily to a diverse group of clinicians in all arenas relevant to human genetics and genomics. This training program will train future medical genetics leaders who are willing and able to apply modern research methods to elucidating the pathogenesis and pathophysiology of medical genetic conditions, as well as understanding how genetics and genomics will contribute to health maintenance through preventative care, so that new and more effective therapeutic interventions can be identified.